CORE CENTER GRANT

The Wilmer Core Grant has productively supported over thirty National Eye Institute-funded principal investigators with the following four modules: 1. Electron Microscopy 2. Computer 3. Biostatistics/Clinical Vision Research Center 4. Machine Shop We plan continuation of these four service areas, with the addition of a fifth module: 5. Molecular Biology and Genetics Each of the Core units will provide important research enhancement to a moderate or maximum usage level for at least eight National Eye Institute funded researchers, with facilitation of collaborative studies. We will encourage some sharing of Core Grant resources and services with non-NEI funded collaborators and with investigators new to vision research, as time permits.